3D Functional Photoacoustic Imaging of Human Brain with a Stretchable Ultrasound Matrix Array

PROJECT SUMMARY/ABSTRACT
Included in Research Plan

Public health relevance
PROJECT NARRATIVE Not Applicable